Biomechanical Effects of Industrial Eccentric Exertions

[unreadable] DESCRIPTION: This research studies the effects of repetitive eccentric exertions in industrial power hand tool operation on biomechanical properties of muscle and tendon in order to better understand the etiology and prevention of work related musculoskeletal disorders. It is hypothesized that increased power tool reaction force and build-up time corresponds with greater changes in the dymanic characteristics of the upper limb. A laboratory-based experiment will define the short-term relationship between repetitive eccentric exertions (i.e. reaction force magnitude and build-up time) and upper limb properties (i.e. stiffness, viscous damping and inertial mass). Subjects will repetitively resist forearm supination against a motor for simulating eccentric exertion levels representative of pistol grip power hand tool operation. Peak torque levels and build-up time will be experimentally controlled. Forearm mechanical properties will be measured before and following a period of work. Mechanical parameters will be ascertained using a unique apparatus that models the forearm as a single degree-of-freedom dynamic mechanical system by measuring the angular displacement of a disturbance to a known mechanical system in free oscillation when the subject uses maximal effort to oppose its motion. Our preliminary data reveals that significant stiffness and inertial mass changes are observed when exercising eccentrically at similar intensity levels. Biochemical measures of blood creatine kinase (CK), and anatomical measures using T2 changes in an MRI of the forearms will be compared with biomechanical parameters prior to, and following repetitive eccentric exertions for a random subset of the subjects. Subjective discomfort will be assessed using a visual analog scale, and forearm edema and strength will also be measured. The second experiment will assess similar upper limb biomechanical properties for industrial workers who regularly perform repetitive eccentric exertions of varying intensity, build-up time and repetition rate in selected industrial jobs. Subjects will be recruited from tool operation jobs on a local automobile assembly line. This research can ultimately lead to better ergonomic interventions through quantitative power hand tool design guidelines and work practices based on understanding the damaging effects of exposure to specific levels of reaction force, build-up time and repetition, as well as providing new outcome measures for epidemiological studies.